Mechanism and effects of communication between actin and gene regulatory complexes

Abstract
Although many studies have demonstrated correlations between cytoskeletal dynamics, genome organization,
and gene expression, the underlying mechanisms linking them remain unclear. Recently, we discovered
crosstalk between the Wiskott-Aldrich syndrome protein family verprolin homolog (WAVE) regulatory complex
(WRC), which promotes actin polymerization, and the Spt-Ada-Gcn5-acetyltransferase (SAGA) complex, a
transcriptional coactivator. Their relationship is established through the sharing of subunits comprising the
SAGA deubiquitinase module, including the deubiquitinase Non-stop. Deubiquitinase module mutations—for
example, polyglutamine expansion in ataxin 7 (ATXN7)—lead to a spectrum of phenotypes not explained by
SAGA’s transcriptional coactivator function, including nervous system degeneration and blindness. In both the
nervous system and the eye, the WRC is an essential promoter of actin polymerization, which is facilitated by
the constitutively active enzymatic subunit WAVE. WAVE activity and localization are regulated by the
remaining WRC subunits, ensuring spatial and temporal control of actin polymerization. Misregulation of actin
polymerizing complexes results in a similar spectrum of phenotypes as seen in SAGA mutants, including
nervous system degeneration and blindness. This suggests that SAGA is important in the nervous system and
eye because it is required to control the WRC in these tissues. We found that the SAGA deubiquitinase module
leaves SAGA to bind the WRC. There, Non-stop deubiquitinates WAVE, increasing its level in both the
cytoplasm and the nucleus. Therefore, we hypothesize that SAGA controls WRC complex composition,
amount, and location; and it is through these activities that SAGA accomplishes functions we had previously
attributed to SAGA alone. This hypotheses will be investigated in three aims. First, we will identify and
characterize nuclear WAVE-containing complexes through affinity purification and column chromatography
coupled to mass spectrometry. Because WAVE activity is regulated in part by its localization, the locations of
these complexes will be determined, and the effects of Atxn7 polyglutamine expansion on complex
composition and localization will be tested. Second, interactions between the SAGA deubiquitinase module
and WRC will be disrupted in cells and flies to determine which SAGA/WRC functions require them. Lastly, the
effects of SAGA deubiquitinase-WRC interactions on blindness and neurodegeneration will be investigated in
flies, by disrupting them and measuring phenotypes characteristic of Atxn7 polyglutamine expansion. These
studies will provide novel insight on the causes of neurodegeneration and blindness, in addition to the links
between transcriptional and cytoskeletal regulatory complexes.

Public health relevance
Narrative Although a strikingly similar spectrum of disease symptoms, including blindness and neurodegeneration, are associated with the misregulation of protein complexes critical for controlling gene expression and cytoskeletal organization, the mechanisms linking the regulation of these complexes are not well understood. Here, we leverage a newly identified regulatory axis between the gene regulatory complex “SAGA” and the cytoskeletal regulatory complex “WRC” to understand the molecular components involved in this regulatory pathway, the basic mechanisms of their co-regulation, and the major biological functions that depend on their interplay. These experiments will provide new insight into the underlying mechanisms contributing to blindness and neurodegeneration and inform the search for new therapeutics to treat these devastating diseases.